Functional interrogation of sensory neurons in inflammation

PROJECT SUMMARY: Chronic inflammatory diseases afflict millions of Americans and place devasting burdens
on patient’s lives. Effective treatments for these disorders are lacking, partly because the multicellular
interactions between bodily systems (e.g. the peripheral nervous and immune systems) that drive inflammation
are poorly understood. For example, it is known that sensory neurons play context-dependent roles in a variety
of inflammatory disorders by modulating the immune response. The specific neuronal subtypes and molecular
mechanisms that contribute to this remain unclear. The overarching goal of my research is to unravel the precise
mechanisms by which peripheral sensory neurons influence the pathogenesis of inflammatory diseases of the
skin and visceral organs and how sensory neurons are in turn influenced by the immune system. A subtype of
sensory neuron that detects itch (pruriceptors), expresses a number of receptors for pro-inflammatory and
immunomodulatory molecules. Thus, these pruriceptors are attractive candidates for orchestrating multicellular
interactions during inflammation. However, the role of these specific sensory neurons in inflammatory disease is
unstudied as, until recently, the tools to precisely target these neurons were lacking. To bridge this gap in
knowledge, this proposal will elucidate the contribution of pruriceptors to distinct inflammatory states. The
proposed research will interrogate pruriceptor function using genetic and viral approaches in mouse models to
selectively target and ablate these neurons and measure the effects of these manipulations on mouse models
of inflammatory diseases. Specifically, I will test the hypothesis that pruriceptors, as polymodal sensors of
aversive chemical, mechanical, and immune stimuli, drive hypersensitivity and local inflammatory responses in
a context-specific manner. During the K99 phase, I will leverage my proven track record in studying neuroimmune
interactions with innovative techniques I am learning to target and manipulate specific subsets of sensory
neurons and ultimately map and elucidate multicellular circuits in inflammation. Aim 1 will establish th e
contributions of pruriceptors to chronic itch-evoked skin inflammation by combining viral and genetic approaches
to selectively ablate pruriceptors with behavioral, immunological, electrophysiological, and transcriptomic read-
outs to understand how pruriceptors contribute to skin inflammation. As molecularly similar sensory neurons of
unknown function also innervate the gut, Aim 2 will translate this approach to the study of gastrointestinal tract
inflammation and gut function using a model of gastritis. I will dedicate part of the K99 phase to career
development activities such as mentoring, presenting at conferences, and publishing research articles. A portion
of both Aims will carry over into the independent R00 phase of the award. This proposal will provide fundamental
insights into the multicellular interactions underlying chronic inflammatory disease from a neuron-focused
perspective. Successfully executing this training plan with the help of The Scripps Research Institute will prepare
me to lead an independent research program.

Public health relevance
PROJECT NARRATIVE: It is increasingly appreciated that multicellular interactions between the peripheral nervous system and immune cells drive the pathogenesis of chronic inflammatory diseases, and that understanding these interactions represents a major milestone toward developing effective treatments for these highly prevalent and debilitating disorders. The goal of this proposal is to determine how peripheral sensory neurons influence the pathogenesis of inflammatory diseases of the skin and visceral organs. This research will provide a basic understanding into the role of neuroimmune crosstalk in inflammation and inform the development of novel therapeutics for chronic inflammatory diseases.